Neurodiagnostic, Proteomic, and Metabolomic Investigations into Down Syndrome Regression Disorder

ABSTRACT:
Dr. Jonathan D. Santoro is a physician-scientist focused on exploring the interface between neuroinflammation
and neuropsychiatric disease in persons with Down syndrome (DS). Dr. Santoro is an international expert in
Down Syndrome Regression Disorder (DSRD), a neuropsychiatric condition in persons with DS which causes
acute or subacute onset bradykinesia, catatonia, delusions, hallucinations, mutism and the loss of ability to
perform activities of daily living. This disease is devasting to both the patient and their caregivers given the
high degree of disability associated with it. Dr. Santoro has spent the last five years identifying the potential
role of neuroinflammation in individuals with this disease and has led multiple successful initiatives to treat this
disease with immunotherapy.
This five-year proposal will be the first comprehensive assessment utilizing neurodiagnostic studies (EEG,
MRI, TCD, and lumbar puncture) and “multi-omics” analysis of the serum and cerebrospinal fluid to directly
compare individuals with DSRD to individuals with DS without Regression (DSwR). Preliminary data has found
that individuals with DSRD have significantly higher rates of neurodiagnostic abnormalities compared to
individuals with DSwR and this is associated with higher rates of response to immunotherapeutics. Further,
early stage “multi-omics” analysis has identified that upregulated immunoglobulin production and increased
permeability of the blood-brain barrier may be a potential pathologic mechanism for this condition.
This study will also employ advanced machine-based learning techniques to determine if advanced
neurodiagnostic profiling can predict responses to treatments and potentially yield a unifying mechanism for
this dreadful condition.
By combining a multidisciplinary team of experts in DS, neuroradiology, multi-omics, and machine-based
learning, the PI hopes to yield critically important data on the role of neuroinflammation in DSRD with the
hopes of expanding investigations to autism spectrum disorder, epilepsy and moyamoya disease in the future.

Public health relevance
Project Narrative: Down Syndrome Regression Disorder (DSRD) is a devastating neuropsychiatric condition causing an acute or subacute onset of bradykinesia, catatonia, delusions, hallucinations, mutism and loss of ability to perform activities of daily living. The proposed five-year research plan will comprehensively evaluate neurodiagnostic, proteomic, metabolomic, and cytokine-mediated abnormalities which will reveal the underlying neuroinflammatory mechanisms to this disease. Using machine-based learning, this study will also seek to perform advanced predictive modelling using the comprehensive data sets generated which may aid clinicians in the choice of therapeutics for DSRD in the future.